Nonlinguistic cognitive processing commonalities among linguistically diverse learners with developmental language disorder

Project Summary/Abstract
Children with developmental language disorder (DLD) demonstrate language deficits in
comparison to unaffected peers from similar language-learning environments. Because of the
diversity in children’s language-learning environments, the linguistic characteristics of DLD
differ across children. However, affected children may share common underlying deficits in
cognitive processing skills such as processing speed, working memory, and sustained selective
attention. This project systematically examines the cognitive processing profiles of individual
children with DLD from different language-learning environments to identify common patterns
of deficit and utilize them to identify DLD. We include children aged 5- to 7-years from three
different language groups (English only, Spanish-English, and Vietnamese-English); within each
of these three groups, both children with typical development (n = 60 per group; n = 180 total)
and children with DLD (n = 20 per group; n = 60 total) are represented. Participants will
complete assessments of processing speed, working memory, and sustained selective attention
in the visual and auditory modalities using nonlinguistic stimuli to avoid bias based on linguistic
experience (for bilingual children) or linguistic deficits (for children with DLD). The project will
establish the reliability and validity of each assessment task to ensure suitability for clinical use
(Aim 1). Cluster analyses will determine common profiles of cognitive processing skill and
whether these profiles differ for children with and without DLD (Aim 2). Diagnostic accuracy
analyses will be conducted to determine whether nonlinguistic cognitive processing tasks can
identify children with DLD within a diverse group of language learners (Aim 3). This project will
advance understanding of the underlying cognitive mechanisms that contribute to DLD by
examining commonalities across children learning language in diverse circumstances. It will
also establish a novel and universal approach to DLD identification that will reduce disparities
across children.

Public health relevance
Project Narrative (Public relevance statement) This project enhances understanding of developmental language disorder within diverse populations. Children with developmental language disorder have different profiles of language deficits that reflect their language-learning environments, but they may share common underlying deficits in basic cognitive processing skills such as attention, memory, and processing speed. This project will investigate these processing skills at the individual level in monolingual and bilingual school-age children with and without developmental language disorder and determine whether deficits in cognitive processing skills can contribute to effective identification of developmental language disorder in children who have different language- learning experiences.